Establishing a Screening Tool for Early Detection of PTSD following Complicated Childbirth

PROJECT SUMMARY: Maternal mental health disorders are the leading identifiable cause of childbirth-related
maternal death in the U.S. and a significant contributor to maternal morbidity and health disparities. Among these
disorders, childbirth-related posttraumatic stress disorder (CB-PTSD) remains an underdiagnosed and
debilitating condition. CB-PTSD affects approximately 240,000 American women annually who experience
traumatic childbirth. It is marked by symptoms that emerge soon after delivery and are triggered by reminders of
the traumatic birth, with the child often becoming an unfortunate symptom enhancer. This dynamic can impair
mother-infant bonding during critical developmental stages. The urgency of addressing CB-PTSD is heightened
by its intersection with life-threatening complications during childbirth and severe maternal morbidity (SMM),
which are highest in the U.S. among Western countries and disproportionately affect minoritized women. Hence,
the need to understand and mitigate the psychological aftermath of medically complicated childbirth. Despite
recommendations for universal maternal mental health screening in U.S. hospitals, no tools currently exist to
identify women at risk for CB-PTSD before symptoms fully develop. This proposal seeks to address this critical
gap by developing an innovative, multi-modal screening tool for early detection of CB-PTSD.
Leveraging the unique opportunity afforded by childbirth trauma, a clearly defined event with early symptom
onset, we propose a prospective, longitudinal study to assess women with complicated, potentially traumatic
deliveries. Beginning in the first postpartum days, we will collect oral unstructured short childbirth narratives at
the bedside depicting the subjective birth experience. We will measure psychophysiological responses during
recollection of the childbirth trauma using validated methods to assess objective emotional reactivity. Obstetrical
data, a proxy of the magnitude of the traumatic childbirth event, will be obtained from electronic medical records.
Participants will be followed at multiple postpartum time points (Week 2, and Months 1, 3, 6) to assess acute
and chronic CB-PTSD via validated psychometric tools and diagnostics. In our prior work, the potential for
artificial intelligence (AI) models to detect CB-PTSD via childbirth narratives is demonstrated. We will expand
this innovative line of research in this application. Using state-of-the-art AI and large language models (LLMs),
we will analyze these narratives and develop a machine learning framework that integrates subjective accounts,
objective physiological markers, and obstetrical indicators to predict CB-PTSD risk. The anticipated outcomes
include a cost-effective, scalable screening tool to identify CB-PTSD risk early, enabling timely interventions and
setting a new standard for trauma-focused postpartum mental health care. This project addresses an unmet
clinical need, aligning with national priorities to reduce adverse maternal and child outcomes and to mitigate
racial disparities in maternal health.

Public health relevance
PUBLIC HEALTH RELEVANCE Medically complicated, traumatic deliveries, which result in severe maternal and neonatal morbidities, have short- and long-term consequences for maternal health and are highest in the US among Western countries, disproportionally affect minoritized women. Beyond the physical toll, complicated deliveries significantly increase the risk for developing childbirth-related posttraumatic stress disorder (CB-PTSD), a mental illness that can undermine both maternal and infant health and deter future pregnancies. This study aims to establish a cost- effective screener of individuals likely to develop CB-PTSD that could be implemented in postpartum units, laying the foundation for holistic perinatal care that supports women following birth trauma.